Ovcoming PARP Inhibitor Resistance

Abstract
This proposal aims to investigate the mechanisms underlying PARP inhibitor (PARPi) resistance
in prostate cancer and identify potential strategies to overcome this resistance. Prostate cancer
is a prevalent cancer in men, and recently, PARPi has been approved to treat metastatic castrate-
resistant prostate cancer (mCRPC) patients whose disease has stopped responding to second-
generation anti-androgens and whose cancers are homologous recombination deficient (HRD).
While some patients treated with PAPRi show promising results, a significant percentage of
patients do not respond to these drugs even with HRD. In addition, acquired resistance inevitably
develops. Thus, it is critical to identify mechanisms contributing to PARPi resistance. We have
discovered that a specific isoform of histone methyltransferase NSD3, called NSD3S, is
overexpressed in PARPi-resistant prostate cancer cells. Based on our preliminary data, we
hypothesize that NSD3S plays a crucial role in driving PARPi resistance through its influence on
replication fork dynamics. Furthermore, we have found that the NSD3S is regulated by a CRL E3
ubiquitin ligase whose misregulation contributes to NSD3S high expression in PARPi-resistant
cells. We propose three specific aims to test these hypotheses. Aim 1 aims to investigate the
mechanistic role of NSD3S in regulating DNA replication dynamics and its contribution to PARPi
resistance. Aim 2 focuses on understanding the mechanisms responsible for NSD3S upregulation
in PARPi-resistant lines. Aim 3 aims to explore new approaches based on our results to overcome
PARPi resistance in prostate cancer using in vitro and in vivo models. Successful completion of
this study would not only provide insights into the mechanisms of PARPi resistance and
replication fork dynamics driven by NSD3S but also have implications for the development of
precision medicine approaches in prostate cancer treatment.

Public health relevance
Narrative Prostate cancer is a common cancer in men, and current treatments often involve a combination of surgeries, radiation, chemotherapy, and hormone therapy. A new class of drugs called PARP inhibitors has shown promise in treating advanced prostate cancer that progresses on prior therapy. Unfortunately, not all patients respond well to these drugs, and some develop resistance over time. In this research proposal, we aim to understand why this happens and find ways to overcome it. We have discovered a protein called NSD3S, which is found in higher levels in resistant prostate cancer cells. We believe that NSD3S is involved in making the cancer cells resistant to PARP inhibitors and that it affects the way DNA is copied during cell division. By studying how NSD3S works and how it interacts with other proteins, we hope to find ways to overcome PARP inhibitor resistance and improve treatment options for prostate cancer patients.